Subdermal, implantable monitoring platform for heart attack and heart failure

Project Summary. Heart attacks occur approximately every 40 seconds in the U.S., often without clear
symptoms, leaving many individuals unaware of their condition until serious complications arise. Notably,
one in five heart attacks is silent and can only be diagnosed through in-clinic assessments using both
electrocardiograms (ECG) and cardiac biomarkers, specifically cardiac troponin I (cTnI) and natriuretic
peptide (NT-proBNP). When left untreated, a heart attack can lead to heart failure—a chronic, debilitating
condition that increases the risk of recurrent heart attacks. Therefore, timely alerts regarding individual heart
attack occurrences are essential for effective clinical intervention. While recent advancements in wearable
technology facilitate continuous ECG monitoring, existing biochemical sensors are constrained by single-
use measurements due to the irreversible nature of their biorecognition mechanisms. These single-use
sensors provide only a snapshot of a patient’s biochemical state, limiting the ability to track the dynamics of
biomarker levels that are critical for timely intervention in conditions like heart attacks and heart failure.
This study aims to develop a real-time, continuous monitoring platform to track cTnI and NT-proBNP
levels alongside ECG readings, with the potential to detect heart attacks before the onset of symptoms and
to monitor the progression of heart failure. Aim 1 focuses on developing a cTnI and NT-proBNP monitoring
module that leverages reversible aptamer switch engineering. Aim 2 involves constructing a multimodal real-
time biosensing platform that will integrate a 3D-printed, flexible subdermal biochemical sensor with an
external wearable device for ECG recording. Aim 3 will then focus on testing and validating this subdermal
biochemical-electrophysiological monitoring platform in a heart failure rat model.
This platform has transformative translational potential for individuals with a history of heart attacks
or heart failure, enabling personalized cardiac care and proactive management of recurrent episodes.
Additionally, this platform can be adapted to monitor a wide range of biomarkers beyond cardiac indicators
by leveraging similar aptamer or molecular switch mechanisms. Expanding this technology could restructure
diagnostics across multiple diseases, enabling a truly personalized system that accounts for individual
variation rather than pooled averages, thereby enriching our understanding of disease processes and
facilitating earlier detection and intervention.

Public health relevance
Cardiovascular disease carries a high risk of recurrent heart attacks, frequently leading to heart failure if there is no timely intervention from medical professionals. We propose a minimally invasive cardiac health monitoring platform that provides timely alerts for individual heart attacks, by continuously tracking both biochemical and electrophysiological cardiac biomarkers in real time. By leveraging cutting-edge technologies in molecular engineering, additive manufacturing, and wearable bioelectronics, this platform enables early and clinically critical diagnoses of heart attack events and the progression of heart failure, paving the way for personalized medical care.